Advancing novel therapeutics and translational science to close the survivorship gap in pediatric, adolescent and young adult (AYA) lymphoma

PROJECT SUMMARY/ABSTRACT:
Hodgkin Lymphoma (HL) has its first incidence peak in the adolescent and young adults (AYA)
years. Despite the success of chemotherapy and radiation in younger children and older adults,
there has been a gap in survival for AYA. In addition, this group is at risk for decreased access
to clinical trials. With the availability of antibody drug conjugates and immunotherapies that can
treat HL, there is a promise that we can reduce the morbidity of historic chemotherapy and
radiation regimens that limit long term overall survival further in AYAs and in black and Hispanic
patients. In her role as the Scientific Chair of the HL committee in the Children’s Oncology
Group (COG), Dr. Castellino’s goal is to accelerate the incorporation of immunotherapy and
CD30-targeted cellular therapy into children and AYAs through collaborative trials with the
NCTN groups both for initial therapy and for relapsed and refractory disease. She also plans to
deliver trial designs that incorporate emerging tumor-microenvironment and host biology in HL
for better risk stratification and response-based approaches. On a national level she also
proposes advances through leadership in the NODAL data commons and through analyses
linking trial data to extant epidemiologic data and post treatment follow up. At the institutional
level, as the Program leader for Leukemia and Lymphoma at the Aflac Cancer and Blood
Disorders Center of the Winship Cancer Institute, she proposes to lead systematic quality
initiatives to enhance trial enrollment in AYAs and in patients of under-represented race and
ethnicity in Georgia. Her leadership of the leukemia and lymphoma biorepository can be
extended to creating infrastructure to bank lymphoma tissue which can enhance translational
work toward precision trial designs for relapsed HL and rare lymphomas. The effort support
through the R50 award would allow her time to accelerate trials in lymphoma nationally and to
enhance AYA accrual locally. Her experience and productivity to date position her for success in
the role of the R50 Clinical Research specialist.

Public health relevance
PROJECT NARRATIVE: Sharon Castellino, MD, MSc is an experienced and productive Clinical Scientist whose goal is to improve survival for children, adolescents, and young adults (AYAs) with blood cancers and lymphoma. The R50 award will support her leadership in the Children’s Oncology Group to bring curative therapies and accelerate the timeline for trials with novel agents to AYA with Hodgkin lymphoma. At the institutional level, as the leader of the pediatric leukemia and lymphoma program, the R50 support will enable her to create an AYA trial enrollment infrastructure and minority populations otherwise under-represented on NCI clinical trials in Georgia.